PROTOCOL REVIEW AND MONITORING SYSTEM

The Protocol Review and Monitoring System consists of two primary elements: the Site/Modality Committees, and Protocol Review Committee. Funding is requested for salary support for the Protocol Review Committee Chair, the CRSS Manager, the Protocol Development Manager and the Protocol Review Committee Analyst.